Impact of SARS CoV2 on Human Herpesvirus Co-Infections

PROJECT SUMMARY
SARS-CoV2 infection has impacted millions of people worldwide. An estimated 5-10% of individuals continue to
experience complex, long-term symptoms even after recovering from acute SARS-CoV2 infection. Long COVID
has been linked to various risk factors, including the reactivation of persistent viral infections like Epstein-Barr
virus (EBV) and other human herpesviruses. Understanding the timing of persistent virus reactivation is an
important step in devising effective mitigation strategies. Moreover, causal relationships between herpesvirus
reactivation and long COVID remain unclear. Current diagnostic tools are insufficient and there remains an
unmet need for early predictive and prognostic biomarkers. Notably, human herpesviruses such as EBV express
numerous viral microRNAs throughout infection and SARS-CoV2 itself encodes a miRNA-like small noncoding
RNA. Additionally, SARS-CoV2 infection dramatically disrupts the host miRNA environment. Given that miRNAs
are highly stable in circulation and have demonstrated utility as biomarkers for various clinical conditions, we
hypothesize that herpesvirus-encoded miRNAs could serve as diagnostic and/or prognostic indicators of SARS-
CoV2-related illnesses. Our preliminary studies on SARS-CoV2 cases uncovered an increased prevalence of
circulating EBV miRNAs in symptomatic individuals. In this project, we will evaluate circulating viral and host
miRNA signatures in SARS-CoV2 infections. Outcomes of these analyses will shed light on miRNAs that can be
used as systemic biomarkers to aid in stratifying patients and identifying those with active herpesvirus infections.

Public health relevance
Project Narrative Long COVID is a debilitating condition that occurs in 5-10% of individuals who have had SARS-CoV2 infection. Reactivation of underlying chronic viral infections, such as Epstein-Barr virus and other herpesviruses, has been associated with higher risk of developing long COVID. Our proposed studies aim to investigate specific blood- based molecular markers that identify herpesvirus reactivation in acute state infection and potentially stratify course of illnesses linked to SARS-CoV2.